Alzheimer's Disease associated pathology induced by neurotropic viral infection

SUMMARY
Genetic risk factors for Alzheimer's Disease can predict the increased likelihood of acquiring the disease yet it
is becoming more evident that external factors are involved in the neurodegenerative disease progression.
Recently two herpesviruses have been implicated in this disorder as they have been found in diseased tissues
of Alzheimer's patients. Human herpes simplex virus 1 (HSV-1) and Human Herpesvirus 6a (HHV6a) are
neurotropic herpesviruses that establish both lytic and lifelong latent infections of the nervous system. How
these viral pathogens alter the outcome of neurodegenerative disease remains uncharacterized. Alzheimer's
Disease is marked by distinct alterations of host proteins including the misfolding of Tau. Using a novel human
iPSC-derived 3D cortical model system, we observed altered splicing of the mRNA that encodes Tau.
Additionally, we observe a viral infection dependent increase in the accumulation of phospho-Tau, a post
translational modification indicating the misfolding of Tau. These preliminary findings support the hypothesis
that viral infections directly impact the host cell microenvironment resulting in changes in Alzheimer's Disease
markers. The overarching goal of these studies is to identify infectious etiological agents that impact either the
severity or frequency of Alzheimer's Disease progression. The objective of this proposal is to define the
biological impact of neurotropic herpesvirus infections on accumulation of known drivers of Alzheimer's
disease within a physiologically relevant model system. Our first aim will identify and define viral dependent
changes within multiple host proteins involved in neurodegeneration. This will for the first time, a direct link
between neurotropic virus infections and pathogenic neurodegenerations in cells of clinical relevance. The
second aim will use novel RNA labeling protocols to profile the transcriptome from only infected cells within the
3D organoids and will utilize single cell sequencing to characterize the tropism of these neurotropic viruses.
The third aim will utilize 3D organoids that harbor known genetic risk factor mutations found in the onset of
Alzheimer's Disease and will determine if herpesviruses amplify the onset of neurodegenerative progression.
Successful completion will clearly define the viral factors that influence Alzheimer's disease and will provide
insight in pathogenic mechanisms that extend beyond Alzheimer's Disease.

Public health relevance
Project Narrative: Human neurotropic herpesviruses are linked to poor outcomes in Alzheimer's Disease patients. However, a direct link between neurodegenerative alterations and viral infections remains uncharacterized. In this proposed work, we will extend our exciting findings of infection-dependent alterations in drivers of Alzheimer's Disease in a novel 3D cerebral cortical human cell model. Characterization of the biological mechanisms controlled by these viruses will represent a major advance in efforts to combat this disease.